15th Annual NIH CounterACT Network Research Symposium

Project Summary/Abstract The ultimate goal of the 15th Annual CounterACT Network Research Symposium, to be held at the Higgins Hotel in New Orleans, LA on Tuesday, June 22, 2021 – Thursday, June 24, 2021, is to disseminate knowledge to foster and support research and development of new and improved therapeutics for chemical threats to the CounterACT Program's grantees and partners. Chemical threats are toxic chemicals that could be used in a terrorist attack or accidentally released from industrial production, storage, or shipping. They include traditional warfare agents, toxic industrial chemicals, and pesticides. The 15th Annual CounterACT Network Research Symposium (symposium) will facilitate interaction of a national audience of CounterACT scientists, clinicians, and other early stage investigators and post-doctorial researchers representing academic institutions, industry and government. This symposium will align with the CounterACT Programs purpose to support basic and translational research aimed at the identification of better therapeutic medical countermeasures against chemical threat agents, and facilitates their movement through the drug development and regulatory processes in collaboration with other federal departments, agencies, and initiatives. The symposium agenda will be formatted with educational and networking opportunities to encourage CounterACT Program grantees, scientists, and mentees to learn from each other to advance the field. The symposium will be conducted over a 2.5-day period and the agenda will be arranged and formatted the same as past symposiums and in coordination with NIH CounterACT Program leadership. The symposium will include highlights from CounterACT Program grantees and will include a number of keynote presentations, continuing educational sessions, and breakout sessions that will span the topical areas of Respiratory, Neurological, Dermal, Ocular, and Metabolic agents. In addition, time on the agenda will be available for presentations by the U54 Centers of Excellence, for rapid presentations by doctoral and post-doctoral mentees working with CounterACT projects, and for multiple poster session blocks. This symposium is highly significant because it will give CounterACT Centers of Excellence, grantees, and others working in the field a platform to disseminate and present cutting-edge research with the latest technological advances in science and medicine for a more rapid and effective response during chemical emergencies.

Public health relevance
Narrative The 15th Annual CounterACT Network Research Symposium will be held at the Higgins Hotel in New Orleans, LA on Tuesday, June 22, 2021 – Thursday, June 24, 2021. The overall goal of the symposium is to disseminate knowledge across CounterACT Network to foster and support research and development of new and improved therapeutics for chemical threats. This symposium will support the dissemination of and education around the basic and translational research conducted across CounterACT funded centers, projects, and programs.